VA Aripiprazole vs. Esketamine for Treatment of Depression VAST-D II

Project Summary/Abstract
Among all medical, mental health and substance related disorders, Major Depressive Disorder (MDD) is the
leading cause disease burden worldwide; MDD is a major cause of suffering and disability for those receiving
their care from the Veterans Health Administration (VHA). Current treatments have limited effectiveness as
only about 30% of patients achieve remission with the first antidepressant treatment. By regulatory convention,
the term treatment-resistant depression (TRD) is used when a depressed patient has not responded to two or
more adequate treatment trials in the current episode. So defined, patients with TRD account for a
disproportionately large share of treatment resources and, despite such efforts, are at the highest risk to
become chronically ill, develop a complicating substance abuse disorder and/or die by suicide. The CSP 576,
VA Augmentation and Switching Treatments for Improving Depression Outcomes (VAST-D), showed that
adjunctive aripiprazole resulted in a significantly greater likelihood of remission as compared to switching to
bupropion. Secondary analyses of VAST-D demonstrated that the advantage of adjunctive aripiprazole among
12-week remitters was sustained across up to six months of therapy and was evident whether or not patients
had co-occurring PTSD. In 2019 the U.S. Food and Drug Administration (FDA) reviewed intranasal esketamine
as a new therapy for treatment of TRD. The safety and efficacy of esketamine was evaluated in a series of
phase III studies that ultimately led to the FDA approval of esketamine (Spravato) for the treatment of TRD in
adults. The proposed study will be an open-label, parallel-group, randomized clinical trial of up to 6 months
treatment of adjunctive intranasal esketamine vs. adjunctive aripiprazole in Veterans with TRD. This study will
assess the efficacy, safety, and acceptability of adjunctive intranasal esketamine in direct comparison to
adjunctive aripiprazole for therapy of TRD. The primary hypothesis is that participants receiving adjunctive
intranasal esketamine will be significantly more likely to achieve remission after six weeks of treatment as
compared to those who receive adjunctive aripiprazole. Depressive symptoms will be assessed by
independent evaluators without knowledge of treatment assignment using the Quick Inventory of Depressive
Symptomatology clinician rating (QIDS-C), which is a well-validated tool that commonly and is easily translated
across other depression inventory scales. The study is powered to be able to detect an absolute difference in
remission rates of 10% or larger at 6 weeks. Secondary outcomes of interest include symptom reduction
across 6 months of randomized therapy, side effects and other tolerability indices, suicidality, and measures of
quality of life and cost-effectiveness.

Public health relevance
Project Narrative Major Depressive Disorder is a potentially chronic, debilitating disorder that afflicts up to 1 of every 4 Veterans seeking mental health care in the VHA. The public health importance of a new, safe, tolerable and cost- effective treatment for Veterans with treatment-resistant depression (TRD) cannot be overestimated. VAST-D was the first study that showed one strategy for TRD, aripiprazole augmentation, had some advantage over others, but the gains were small in magnitude, leaving room for improvement. Esketamine represents the only currently available approach that holds the promise of being a breakthrough. If it produces greater remission rates, has more sustained benefits with fewer side effects, and lower health-related costs, the benefit to thousands of Veterans and millions of other patients would be substantial. The results of our proposed research thus may provide an empirical basis for revising current practice guidelines. With this large, multi- center study, the VA’s role as a leader in improving the treatment for depression would be firmly established.